CRCNS US-France Research Proposal: Probing the Dorsolateral Prefrontal Cortex and Central Executive Network for Improving Neuromodulation in Depression

The overarching goal of this work is to improve treatments of medication-resistant neuropsychiatric diseases with
repetitive transcranial stimulation (rTMS) by tailoring the target to an individual's brain networks. We are indeed in
critical need of these individualized treatments for mental health disorders, which affect nearly 50% of Americans
during our lifetimes, and brain stimulation treatments, including rTMS represent innovative approaches for these
patients. To alleviate depression, rTMS attempts to target a region of the prefrontal cortex generally located within
the central executive network (CEN), which drives decision making, cognitive control, and is critically impaired in
depression. However, rTMS is delivered without targeting an individual's CEN, and as such may inadvertently
deliver stimulation outside the CEN. This application is motivated by recent developments in the field, including a
large-scale whole-brain connectivity database derived from invasive recordings and the demonstration that rTMS
in depressed patients induces brain changes that predict clinical improvement. In this proposal, we combine non-
invasive TMS studies in healthy subjects and depressed patients with invasive direct stimulation studies from
surgical patients. We test the hypothesis that the CEN connectivity is weakened in depression and can be
maximally modulated by individualizing localization. The project consists of three aims: (1) investigate the
excitability, connectivity, and neuronal properties within the CEN using direct brain recordings in surgical patients
with epilepsy; (2) derive accurate TMS tools to measure CEN connectivity non-invasively in healthy and depressed
populations; and (3) in a depressed population characterize inter-individual variability within the CEN and
prospectively test if localization with TMS at the individual level more effectively modulates this brain network. This
approach, which can be generalized to any brain region and disorder, utilizes a large database of direct brain
recordings to map a brain network at an unparalleled level of detail, develops a link to direct brain recordings in
order to yield validated non-invasive brain measures, and applies these insights to individually localize the network
and improve targeted brain stimulation. Scientific outcomes include: (1) the first causal, functional map of the
human CEN from direct brain recordings; (2) novel non-invasive brain measures of connectivity grounded in
electrophysiology; (3) causal brain signatures of depression in the CEN; (4) a methodology to target an individual's
CEN in the clinic; and (5) improved modulation of the CEN using this methodology. In summary, a successful
outcome of the proposed work would yield an algorithm and guidelines for personalized TMS targeting based on
fully validated brain signatures in depression.
RELEVANCE (See instructions):
Brain stimulation for depression targets the central executive network (CEN), involved in decision making and
cognitive control, core in depression, and difficult to target in the clinic. Here we propose to study the connectivity
of the CEN using a combination of invasive and non-invasive brain recordings; we will 1) investigate CEN
connectivity from direct brain recordings, 2) derive accurate and causal tools to measure CEN connectivity non-
invasively in healthy and depressed populations, and 3) test if CEN localization at the individual level can more
effectively modulate this network. A successful outcome of the proposed work would yield an algorithm and
guidelines for personalized TMS targeting based on fully validated brain signatures in depression.